Mechanisms of Hematopoietic stem cell development during fetal life

Summary: In the mouse, multipotent erythro-myeloid progenitors are produced through an endothelial-to-
hematopoietic transition (EHT) process, in the vasculature of the yolk sac, between E8-8.5. Starting at E9, a
subset of endothelial cells in the intra-embryonic vasculature undergoes EHT, spanning for around 48 hours
and resulting in the emergence of the first lympho-myeloid progenitors that enter the circulation and home to
the fetal liver (FL). It is in this environment that multipotent progenitors give rise to the hematopoietic stem cell
(HSC) compartment starting at E10.5, but it is only after E12 that HSCs can be identified through the
acquisition of characteristic surface markers such as SLAMF1 (CD150) and Sca1. For a period of 1.5 days,
from E10.5 to E12, HSCs can only be detected indirectly through transplantation experiments, a gap in
knowledge we will address in Aim 1.
The signals promoting the development of HSCs in the FL remain incompletely defined. Stem cell factor
(SCF) and Thrombopoietin (THPO) activate receptor tyrosine kinases (RTK) that play pivotal roles in HSC
proliferation and survival, but also orchestrate the intricate process of hematopoietic multipotent progenitor cell
differentiation into various cell lineages, including lymphoid, myeloid, and megakaryocyte/erythrocyte cells. We
hypothesized that other signals must exist to allow HSC expansion during fetal life while counterbalancing the
pro-differentiation effects of RTK signaling induced by SCF and THPO.
GPCRs signal through heterotrimeric G proteins composed of alpha, beta and gamma subunits, with the
alpha subunit conferring pathway specificity. GPCR signaling via Ga12/13 proteins potently inhibits PI3K
activation such that genetic deficiency in Ga12 or Ga13 results in lymphoproliferative disease and
lymphomagenesis. In recent and unpublished studies, we uncovered a critical role for the Ga12/13-coupled
GPCRs GPR56 and GPR97 in HSCs. Specifically, we demonstrate that deficiency in both receptors is lethal
due to a complete loss of HSCs during embryogenesis, while induced deficiency in both receptors in HSCs of
adult mice leads to the complete loss of HSCs and adult hematopoiesis. Our findings provide the foundation for
a new paradigm in which HSC homeostasis is controlled by a balance between stimulatory (RTKs) and
inhibitory (GPCRs) pathways. The central goal of this grant proposal is to precisely define the role of GPR56
and GPR97 in HSCs. In Aim 1 we will test if Gpr56 protein expression marks the birth of the first HSC in early
embryonic stages (starting at E9). In Aim 2, we will directly test if GPR56 and GPR97 counter-balance cKit
signaling using a combination of in vitro and in vivo experiments that will modulate cKit signaling intensity. We
will also study the transcriptional hubs controlled by GPR56 and GPR97 in fetal liver HSCs by bulk and
scRNAseq. Together, the experiments described in these aims will reveal novel mechanisms and fundamental
new principles of HSC homeostasis and multilineage differentiation.

Public health relevance
Although hematopoietic stem cells have been identified almost 50 years ago there is still a poor understanding of how stemness is regulated. This research program will investigate the major pathways controlling stemness in hematopoietic stem cells during fetal life.